Uncovering how chaperones assist in protein folding and preventing toxic protein aggregates

Project Summary/Abstract
Proteins carry out the majority of cellular functions and are essential for cellular activities. Most proteins
must fold into the correct shape to fulfill their functions and need to endure constantly changing conditions
within the cell. However, proteins cannot accomplish this on their own; they rely heavily on chaperones.
Different chaperones fulfill various functions to ensure proteostasis. Here, we focus on Hsp60 and Hsp10,
which assist in protein folding and prevent protein aggregation. Protein misfolding is implicated in many
severe diseases such as Alzheimer's disease, Parkinson's disease, Creutzfeldt-Jakob disease, cystic
fibrosis, and Huntington's disease. Despite decades of research, there is a fundamental gap in understanding
the molecular mechanisms underlying the protective role of chaperones.
This proposal will address four key questions: 1. How does ATP induce a simultaneous conformational
change in all subunits of Hsp60? ATP can bind to each subunit of the heptameric or tetradecameric Hsp60
inducing an enormous conformational change. It is a cooperative process, but how the different subunits
communicate with each other remains unknown. Understanding this allosteric mechanism is key to
comprehending the kinetic cycle of Hsp60, which involves native substrate binding, encapsulation, and
release of the folded substrate. 2. How do substrates interact with a chaperone? Is there a common
binding motif? What is the timescale? A given chaperone can interact with many different client proteins.
This study aims to determine if there is a common binding motif for substrates when interacting with the
chaperone. This will provide detailed molecular principles of how substrates interact with chaperones, and
this knowledge is valuable to provide insights into the chaperone's selectivity and its ability to handle various
types of substrates. 3. What is the purpose of the tails of Hsp60? Several chaperones have unstructured
flanking regions that are essential for their function. However, due to their flexible nature, these regions are
not easily accessible to most biochemical methods. Solution-state NMR can provide visualization of how
these regions interact with substrates, unraveling their contribution to substrate binding and encapsulation.
4. What is the role of the co-chaperone, Hsp10? Hsp10 has been overlooked for many decades, thought
to be merely the helper of Hsp60. Recent studies reveal that Hsp10, in the absence of Hsp60, assists in
protein folding and inhibits protein aggregation. Studies, how Hsp10 in the absence of Hsp60 interacts with
substrates will help understand how Hsp10 contributes to proteostasis.
The combination of all these studies will shed light on fundamental questions about the mechanisms that
chaperones and co-chaperones use to efficiently fold proteins into their functional forms and prevent
aggregation. A process which crucial to maintaining protein homeostasis, which is vital for life.

Public health relevance
Project Narrative Chaperones play a crucial role in maintaining protein homeostasis and preventing the formation of toxic protein aggregates. The failure of this control mechanism frequently leads to protein misfolding diseases like Alzheimer’s, Parkinson’s, Huntington’s, Creutzfeldt-Jakob disease, or Cystic fibrosis. The goal of this proposal is to enhance our understanding of how chaperones function, paving the way for therapeutic strategies against protein misfolding diseases.